PRECLINICAL AND CLINICAL STUDIES ON CONVERTING B ERYTHROCYTES TO GROUP O

The studies continue to show the survival, efficacy and safety of transfusions with enzymatically altered red blood cells in normal volunteers.